Identifying the superior ossification pathway for tissue engineered approaches to long bone repair

PROJECT SUMMARY
Musculoskeletal health is a key determinant of mobility and quality of life which affects every individual,
regardless of age. Up to 20% of the 6 million fractures occurring annually in the US will result in nonunion or
slow healing and require intervention for bone regeneration. Mesenchymal stromal cells (MSCs) are one
alternative to bone grafts because of their osteogenic, chondrogenic, and proangiogenic potential. Compared
to monodisperse cells, MSC spheroids better resist apoptosis and secrete 100-fold higher levels of angiogenic
factors while retaining their multipotency. However, MSC spheroids are not yet sufficient to bridge large bone
defects, suggesting the need for effective programming methods to enhance their bone-forming potential.
Furthermore, it is unclear whether bone healing is more effective by jumpstarting cartilage formation or
attempting to induce osteogenic differentiation of resident or transplanted cells. Local delivery of inductive
growth factors such as BMP-2 and TGF-b1 accelerates tissue formation, but the necessary supraphysiological
concentrations and associated complications impair their widespread clinical use. Our data demonstrate that
MSC spheroids loaded with cell-secreted extracellular matrix (ECM) are more responsive to potent mitogens
and exhibit enhanced osteogenic and chondrogenic differentiation while using markedly reduced dosages and
reducing contraindications. Thus, our central hypothesis is that MSC spheroids can be differentiated in situ
toward the osteogenic or chondrogenic lineage by presenting inductive cues adsorbed to incorporated ECM,
which will yield potent cellular building blocks to regenerate large lost bone volumes. Aim 1. Adapt cell-
secreted ECM to locally present inductive factors to MSCs within spheroids to enhance osteogenic or
chondrogenic differentiation. We will test the role of ECM quantity and BMP-2 and TGF-b1 dosage on growth
factor retention and presentation of loaded morphogens and correlating their resulting effect on osteogenesis
and chondrogenesis in vitro. Aim 2. Potentiate MSC osteogenic or chondrogenic differentiation by
manipulating ECM-driven morphogen presentation. We will identify and quantify changes in integrin expression
and growth factor receptor activity in MSC spheroids containing ECM-adsorbed BMP-2 or TGF-b1. We will
then assess changes in MSC differentiation when decoupling the synergy of cell adhesion and growth factor
availability. Aim 3. Establish the therapeutic potential of ECM-adsorbed exogenous morphogens to instruct
MSC spheroids in situ for bone formation. We will determine the capacity of MSC spheroids containing ECM-
adsorbed BMP-2 or TGF-b1 to persist, undergo osteogenic or chondrogenic differentiation in situ, and repair
large bone defects. We will use noninvasive imaging and histology to describe the superior pathway to
promote robust bone formation in long bone defects. The proposed research is innovative because it provides
a novel strategy to reduce the quantity of recombinant growth factors needed to guide cell function, while
establishing whether MSCs directed toward cartilage or bone achieve faster bone repair in long bones.

Public health relevance
NARRATIVE The development of new approaches to enhance the therapeutic potential of autologous bone-forming cells will provide valuable and necessary options to clinicians treating bone defects, especially for cases of slow-healing or nonhealing damage, and cases that require minimal immune and other side effects. We seek to determine if applying novel programming methods to aggregates of progenitor cells, right before implantation, will enhance their reparative function for bone regeneration.